Kratom and Cannabinoid Constituents: Mechanisms and Interactive Effects in Neuropathic Pain

As the opioid crisis continues in the US, those suffering from chronic pain look to perceived safer and more
effective treatment options, including natural remedies. The scientific evidence, practice, and legislation
surrounding the medical use of Cannabis has been steadily on the rise over the last several decades, with pain
reduction and alleviation of anxiety as its top indications. In addition, Kratom, a coffee-like plant containing
compounds that cause opioid and stimulant effects, has also gained popularity for self-treatment of several
symptoms, including chronic pain, prescription opioid dependence, and anxiety. A recent survey of Kratom
users reported that the strongest predictor of Kratom use was Cannabis use, specifically cannabidiol (CBD).
Indeed, the marketing and sale of Kratom and CBD side by side is on the rise, represented by shops such as
CBD Kratom©. To date there are no studies to investigate whether and how Kratom and Cannabis constituents
may interact. Therefore, it is critical to understand 1) the unique and shared pharmacological actions of
Cannabis and Kratom constituents, and 2) whether and how these constituents may act when used together to
impact potential efficacy and adverse effects. The Ward laboratory was the first to report that the non-
psychoactive cannabis constituent CBD significantly attenuated chemotherapy-induced neuropathic pain in
mice, and this effect involved interactions with the serotonin 5-HT1A receptor. Most recently, we have
determined that another Cannabis constituent cannabigerol (CBG) also attenuates mechanical sensitivity in a
mouse model of oxaliplatin associated neuropathic pain, this time through cannabinoid and adrenergic
mechanisms. The Rawls laboratory first reported in 2020 that the bioactive alkaloid of Kratom, mitragynine,
significantly reduced oxaliplatin-induced mechanical allodynia in rats, and this effect involved interactions with
µ-opioid receptors and adrenergic receptors. Therefore, in addition to their potential anti-neuropathic effects,
these Cannabis and Kratom constituents also share a complex and overlapping polypharmacology. For
example, CBG and mitragynine may share direct antagonistic effects on α2 adrenoreceptors, and all three
compounds may interact with cannabinoid and serotonin receptors to in part mediate their behavioral effects.
Understanding of the receptor and molecular targets for mitragynine and CBG is at its infancy, and the extent
to which CBD, CBG, and mitragynine possess unique but overlapping mechanisms of action remains to be
systematically studied. Furthermore, this likelihood of unique and overlapping mechanisms of action strongly
supports that these constituents will work synergistically in combination, whether it be toward potentiating
putative therapeutic effects or exacerbating adverse effects. This R21 application proposes complementary in
vivo, ex vivo, and in vitro experiments to systematically determine receptor, signaling, and gene expression
interactions underlying the effects of CBD, CBG, and mitragynine, and their interactive effects in mouse
models of neuropathic pain, inflammatory pain, anxiety, and body temperature.

Public health relevance
As the opioid crisis continues in the US, those suffering from chronic pain and opioid use dependence look to perceived safer and more effective treatment options, including natural remedies such as cannabis and Kratom. A recent survey of Kratom users reported that the strongest predictor of Kratom use is Cannabis use, and the marketing and sale of Kratom and CBD side by side is on the rise. To date there are no studies to investigate whether and how Kratom and Cannabis constituents may interact, therefore we propose to systematically determine whether cannabis and Kratom constituents work similarly to alleviate chronic pain, and whether when taken together, potential therapeutic or adverse effects are magnified.